Targeting T Cells for enhancing anti-tumor immunity in pediatric brain tumors.

PROJECT SUMMARY
We will undertake hypothesis-driven, mechanistic studies to demonstrate the functional role of tumor
neoantigen-specific T cells in pediatric brain tumors (PBT). Brain tumors represent the most common solid
tumors in children, and a high proportion of patients have devastating outcomes despite multimodal therapy.
Most notably, immunotherapies that show remarkable success in adult cancers are not approved for PBT. The
notion that brain tumors are immune-cold with low mutational burden has precluded assessment of
immunotherapies in children. Our recent studies (Nature Cancer, 2024) provide a compelling hypothesis that
neoantigen-specific T cells are present in the brain tumor tissue, and therapies to boost their numbers and activity,
like PD-1 blockers and neoantigen-directed vaccines, are likely to be beneficial.
We established the TARGET BRAIN study (PI: Dr. Ganesan), a prospective observational cohort of children
with brain tumors who undergo surgical resection (40 cases/year) at Rady Children’s Hospital, UC San Diego.
Given the outcome disparities in PBT, a major focus of TARGET BRAIN is the inclusion of ethnically-diverse
population and those under-represented in research (current enrollment−52% female, 58% Latino, 30% non-
Hispanic White, 8% African-American, 4% Asian). From this cohort, we performed the first and in-depth survey
of single-cell transcriptomes with paired T cell clonality studies using purified tumor-infiltrating CD8+ T cells (TILs)
isolated from PBT (n=38). We found striking clonal expansion of CD8+ TILs which displayed effector program,
tissue-residency, high levels of PD-1 expression and enrichment for gene signatures of immunotherapy response
and neoantigen-specific T cells. Importantly, we experimentally validated tumor reactivity of TILs in PBT. We
hypothesize that neoantigen-specific CD8+ T (TRM) cells are generated in a substantial fraction of pediatric brain
tumors and are capable of mediating tumor control. We anchor our proposed studies to address this hypothesis
systematically in two important and aggressive brain tumors – medulloblastoma (MB) and high-grade glioma
(pHGG). In Aim 1, we will determine prevalence and transcriptional properties of neoantigen-specific CD8+ T
cells in an ethnically-diverse cohort of children with MB (n=40) and pHGG (n=40). We will perform single-cell
RNA-seq and TCR-seq analysis of CD8+ TILs isolated from brain tumor tissue. To determine TIL TCRs that are
neoantigen-specific, we will test reactivity of T cells from donor-matched PBMC to neoantigens present in
corresponding tumors. By assessing overlap of these experimentally-validated neoantigen-reactive TCRs with
TIL TCR sequences, we will determine neoantigen-specific T cells in tumor. Given that tumor-associated
antigens (TAA) may also drive functionally-relevant TIL responses, we will perform similar analysis to define
TAA-directed T cells. We will couple single-cell TCR-seq with the transcriptomes of CD8+ TILs to determine the
transcriptional properties of neoantigen-specific T cells and TAA-directed T cells. In Aim 2, we will determine
function of neoantigen-specific T cells in controlling MB and pHGG. We will engineer primary T cells to express
neoantigen TCRs and determine their epitope specificity and avidity in vitro. We will test the anti-tumor activity
of neoantigen-specific T cells, by adoptively transferring T cell clones engineered to express neoantigen-reactive
TCRs and assessing their effects on tumor growth in vivo in orthotopic PDX models. These studies will provide
definitive evidence regarding prevalence and function of neoantigen-specific CD8+ T cells in pediatric brain
tumors and propel clinical testing of neoantigen-directed vaccines in children.

Public health relevance
PROJECT NARRATIVE Brain tumors are the most common solid tumors in children, and outcomes remain poor for a significant proportion of patients despite aggressive multimodal therapy. Brain tumors are understudied and considered to be immunologically-silent, however we show striking clonal expansion of tumor-infiltrating CD8+ T cells with a transcriptional program supportive of effector function, tissue-residency, PD-1 expression and neoantigen specificity. The proposed study will determine the prevalence, transcriptional properties and in vivo function of neoantigen-specific CD8+ T cells in an ethnically-diverse patient cohort with pediatric brain tumors (medulloblastoma and pediatric high-grade glioma) using single-cell RNA sequencing, TCR sequencing, TCR engineering and patient-derived xenograft models; translation of these findings will lead to clinical trial testing neoantigen-based immunotherapy in childhood brain tumors.